Transforming Curiosity into Donation: Validating a Risk Prediction Index to Detect and Prevent Drop-Out in Potential Living Kidney Donors who are Racial/Ethnic Minorities

PROJECT SUMMARY
Approximately 1 in 7 US adults have chronic kidney disease (CKD), and >800,000 patients are in full kidney
failure also called end-stage kidney disease (ESKD). The optimal treatment for ESKD is living kidney donor
transplantation (LKDT); however, the standard of care continues to be ongoing dialysis, which has poor clinical
outcomes in comparison to LKDT. CKD continues to increase among Hispanics and low-income patients. Black
and Hispanic/Latino persons are respectively 3.1- and 1.3-times more likely than White persons to develop
ESKD. Many individuals are curious about becoming a living donor, but some decide not to donate for unknown
reasons. This prevents transplant centers and kidney organizations from improving their kidney donation process
and tailoring donor care to overcome barriers, particularly for vulnerable and underserved populations. Drop-out
is especially common for potential donors who are Black and Hispanic, specifically those who face greater
socioeconomic challenges to donating, and those who are not biologically related to their kidney patients. Drop-
out from these groups of potential donors contributes to known disparities in LKDT. To reduce disparities in living
donation and increase LKDT, we propose a multi-step study that includes:
Aim 1a: Early identification of patients of all races/ethnicities at higher risk of dropping out from the donor
evaluation process via secondary data analyses of multiple regional and national donor databases. A tailored
risk prediction index (LD-DROP) will be developed and tailored to characterize the risk of drop-out among
potential donors at the time of initial screening or contact, including subgroup analyses by race, ethnicity, and
socioeconomic status; Aim 1b: Validation of the LD-DROP index by prospectively tracking a large, diverse group
of individuals presenting for living kidney donor evaluation at two large and geographically diverse transplant
centers; Aim 2: Individual interviews of potential living donors of various race, gender, and level of risk for drop-
out will be conducted to explore their decision-making and readiness to donate, what vulnerabilities and barriers
to donation they face, and what financial, psychosocial, peer mentoring, and educational interventions might be
most helpful for overcoming these barriers; Aim 3: An intervention to address donation barriers will be piloted
for potential donors at high drop-out risk through a national online peer support program and transplant center-
based education programs for potential living donors.
Project deliverables will be made freely available nationwide via partnerships with the Scientific Registry of
Transplant Recipients Living Donor Collective initiative and the National Kidney Foundation.

Public health relevance
PROJECT NARRATIVE The Patient Engagement Research Lab and J.C. Walter Jr. Transplant Center at Houston Methodist will partner with Saint Louis University, the Cooperman Barnabas Transplant Center, the National Kidney Foundation, and the Scientific Registry of Transplant Recipients’ Living Donor Collective initiative to improve living donor care and increase the number of potential living donors proceeding to actual donation. A team of scientists, ethicists, patient engagement and education specialists, clinicians, and living donors will conduct a multi-step study to identify clinical factors, social determinants of health, and other modifiable factors that contribute to evaluation discontinuation, especially for potential donors from underserved communities; develop and validate a living donor drop-out risk prediction index (LD-DROP) to identify which individuals would benefit from greater support; conduct community-engaged research to better understand how to support potential living donors at high-risk for drop-out; and pilot a positive donor experience intervention. This project will not only establish critical metrics and resources to better support and tailor the potential transplant donor experience, but also help decrease the kidney shortage by improving living donor support for everyone, particularly communities of color.